BRAIN GLUTAMATE METABOLISM--GC/MS STUDIES

This project involves the study of glutamic acid metabolism in synaptosomes. We will use 15N and 13C as metabolic tracers and gas chromatography-mass spectrometry as an analytic tool to answer these questions: i) How do neurons produce glutamate? Is glutamate the only precursor? Could alanine and the branched-chain amino acids be important N donors? Could 2-oxo-glutarate be an important C donor? ii) How is glutamate synthesis regulated? How is flux through the glutaminase pathway altered during depolarization? What is the effect of Ca2+? Of hypoglycemia? Of hypoxia? iii) How do synaptosomes metabolize glutamate? What is the role of oxidative deamination vs. transamination vs. the purine nucleotide cycle? How is this metabolism altered by hypoglycemia? By hypoxia? By depolarization? A unique feature of the work is our continued use of stable isotopes, particularly 15N, as a metabolic probe for brain nitrogen metabolism and of gas chromatography-mass spectrometry as an analytic tool for the determination of isotopic abundance. The information obtained from this work will provide a new perspective on the metabolism of glutamic acid, the most important excitatory neurotransmitter and the linchpin of all brain nitrogen metabolism. The data also may help us to understand the pathophysiology by which changes in glutamate synthesis and utilization may lead to the irreparable brain damage occurring consequent to anoxia and hypoglycemia, conditions in which glutamate excess is thought to be an important pathophysiologic factor.